Promoting Effective Self-Management of Chronic Pain with mHealth Neurofeedback

ABSTRACT
One in five Americans has chronic pain. Many pharmacological pain interventions exist but increase risk of opioid
abuse. There is a critical need to find safe, accessible, and effective treatments for patients to self-manage pain.
Neurofeedback, or electroencephalogram (EEG) biofeedback, treats pain by training patients to regulate brain
states linked to physiological relaxation. Although neurofeedback has traditionally required travel to clinics, in
the past decade, portable EEG headsets have been validated that read brainwaves and send signals via
Bluetooth to mobile devices. We developed a mobile health (mHealth) platform enabling patients with chronic
pain to conduct neurofeedback at home to self-manage pain. Patients with chronic pain, most with low back pain,
were able to conduct mobile neurofeedback independently, and after three months of use, reported significantly
lower pain intensity and lower pain interference. In the current R01 application, we will conduct a double-blind
randomized controlled trial to test the effects of mobile neurofeedback on pain outcomes. N=150 adults with
chronic low back pain will be randomly assigned to mobile neurofeedback or a placebo-control condition. Each
participant will receive a portable EEG headset and mobile device outfitted with a mobile application (app) called
‘Mobile Neurofeedback’ and be asked to complete 10-minute sessions at least 4 days per week for 12 weeks.
The experimental condition involves a mobile app that provides auditory feedback signaling EEG alpha power
above a threshold level and denoting a physiologically relaxed state. The control condition involves a visually
identical mobile app yoked to a pre-recorded set of actual neurofeedback sessions (i.e., placebo). Data will be
collected at 0, 3, 6, and 9 months. We hypothesize that participants randomized to the experimental condition
will show greater decrease in pain intensity and pain interference and greater increase in speed on a test of
physical function and EEG alpha power at 3, 6, and 9 months compared to participants in the control condition.
We also hypothesize that pain self-efficacy will mediate changes in pain outcomes among participants
randomized to the experimental condition. This research is innovative because it tests a novel mHealth tool that
uniquely enables self-management of pain to be performed easily and safely by patients. This study advances
the field by rigorously testing effectiveness of a cutting-edge, practical mHealth tool to improve quality of life for
patients with chronic low back pain. Mobile neurofeedback enables patients to be active participants in managing
their own health and therefore shows promise to reduce clinic visits. The expected outcome is development of a
portable, low-cost, non-pharmacological intervention pioneering a new framework to treat pain. By applying
mHealth technology to a self-management pain treatment, this study furthers strategic goals of NINR and the
NIH National Pain Strategy. If this study yields positive results, it would demonstrate that mobile neurofeedback
has potential to fundamentally change patients’ ability to effectively self-manage chronic pain.

Public health relevance
PROJECT NARRATIVE To improve quality of life among individuals with chronic [low back] pain, there is a critical need to develop mobile health (mHealth) tools that promote safe, effective, and accessible self-management of pain. This research is innovative because it tests a novel mHealth tool— mobile neurofeedback— that uniquely enables self-management of chronic [low back] pain to be performed easily and safely anytime, anyplace. If this study yields positive results, it has potential to fundamentally change patients’ ability to manage pain on their own.